Administrative/Program Enrichment Core

The Administrative/Program Enrichment Core is the organizational unit responsible for facilitating research in
the basic biology of aging throughout the San Antonio (SA) Nathan Shock Center. The goal of the Core is to
provide continuous leadership and infrastructure that catalyzes scientific discoveries, promotes education and
research career development, and partners with other scientists and the community at large.
The Administrative/Program Enrichment Core will foster and promote transformative research in geroscience
using a comprehensive research platform that integrates studies on longevity (lifespan), integrated physiology
(healthspan), pathology, and molecular phenotypes. These studies will drive discovery of molecular and cellular
mechanisms that influence aging and the development of novel strategies (including the identification of
pharmacologic targets) to promote healthy lifespan. The Administrative Core will monitor, stimulate, sustain,
evaluate, and report progress toward our goals through the following Specific Aims:
1. To provide administrative, budgetary, and regulatory management support for the overall center;
2. To foster education and an environment that stimulates collaborative efforts and synergies among research
resource cores and promotes education and research career development of early-career investigators;
3. To promote interactions in aging research through the sharing of core services with investigators at other
institutions and building collaborations with other Nathan Shock Centers;
4. To provide biostatistical support to all core users, and data management and project tracking for each of
the resource cores;
5. To conduct continuous internal evaluations of the center and periodic external evaluations.
Innovation: To further the continuing development of our center's research programs, the Administrative Core
will incorporate innovative features including:
(1) An innovative web-based project management system to promote efficient monitoring and reporting of
project outcomes and to stimulate collaboration on the analysis of projects supported by the resource cores;
(2) Novel statistical methodology to analyze complex outcomes and phenotypes relevant to aging research;
(3) Facilitation of webinars to be run by the core leaders; as part of the educational and training goals of the
center, webinars will explain and promote the services that can be offered by each core.
The Core will lead to three kinds of progress. First, it will foster a cooperative research environment within
UTHSCSA that will attract investigators to aging research via specific educational programs (i.e., seminars,
faculty and student retreats, and symposia that focus on various aspects of aging). Second, it will foster external
collaborative efforts with other Nathan Shock Centers. Third, it will assist with development and expansion of
aging research at other institutions with fewer resources for biology of aging research compared with UTHSCSA.